Novel NEK2 signaling pathways in myeloma progression

Project Summary
Multiple Myeloma (MM) is a plasma cell malignancy characterized by extensive structural and numerical
chromosomal abnormalities. By comparing consecutive gene expression profiles (GEP) of samples at
baseline, during intensive chemotherapy and at relapse, we have identified chromosomal instability (CIN)
genes associated with poor prognosis in MM disease. One of the CIN genes, the serine-threonine kinase
NEK2, is the most significantly upregulated gene in myeloma cells in patients in complete remission (CR) with
minimal residual disease (MRD) and at relapse early during chemotherapy following tandem transplantations.
We have shown that pharmacological or genetic inhibition of NEK2 delays tumor growth and induces cell
apoptosis in myeloma and high expression of NEK2 has also been related to poor outcomes in many other
cancers. The deubiquitinase (DUB) USP7 stabilizes NEK2 protein resulting in the activation of the NF-
B/heparanase pathway, also involved in bone destruction. However, it is unknown whether NEK2 also
activates USP7. In addition, we have found that NEK2 negatively regulates PD-L1 expression, most likely via
epigenetic modification. High-risk myeloma cells show low levels of PD-L1 expression and are resistant to
immune checkpoint blockade. Therefore, we hypothesize that NEK2 promotes myeloma cell survival, drug
resistance, and disease progression by activating the deubiquitinase USP7 and the histone methyltransferase
EZH2. In order to rigorously test this hypothesis, we will: (1) Identify the major deubiquitination targets
regulated by the Nek2-Usp7 complex using Nek2-transgenic mice with varying levels of Nek2 expression and
controls. We will focus on selecting probable proteins as a proof-of-principle to establish the role of Usp7 as
the signaling hub in this complex. (2) Determine the mechanisms by which NEK2 inhibits responses to immune
checkpoint blockade in myeloma cells using Nek2-knockout mice and biochemical approaches. And, (3)
Develop novel immune therapies for drug-resistant and relapsed myelomas using primary myeloma cells, a
genetic Nek2-knockout mouse model, and a myeloma mouse model. Supported by strong preliminary data that
provide strong rationale for this application, the proposed research is poised to facilitate novel, targeted
approaches to the prevention and treatment of myeloma progression and relapse. We predict that our results
will extend beyond myeloma and also apply to other hematological and solid tumors.

Public health relevance
Project Narrative High expression of NEK2 mediates myeloma cell survival, drug resistance, and bone destruction and is associated with poor patient outcome. We propose to explore how NEK2 promotes myeloma disease progression. We will also investigate the use of combinational immune therapy to prevent myeloma progression and relapse using primary myeloma samples and in vivo mouse models.